Open, interoperable, and configurable clinical decision support modules for OpenMRS, OpenEMR, and beyond

Project summary
Although a clinical decision support system (CDSS) can be an effective tool in clinical settings, such systems
can be irrelevant to current clinical practice without up-to-date CDSS rules. Managing and maintaining CDSS
rules can be resource-intensive, even for large academic medical centers, which typically have more resources
than small medical practices. Our parent R01 project (1R01GM138589) aims to leverage Semantic Web
technology to enable reusable and portable CDSS rules and enable clinicians to independently manage and
maintain CDSS rules. The goal of the parent R01 project is to use the OpenMRS and OpenEMR as examples
to demonstrate feasibility. The administrative supplement project proposes transforming internal codes into
ready-to-distribute modules of OpenMRS and OpenEMR. The administrative supplement project will benefit
existing OpenMRS and OpenEMR communities, i.e., clinicians and patient populations. The major deliverables
of the administrative supplement include ready-to-distribute CDSS modules with comprehensive functionalities,
higher-quality documentation, instructions, and CDSS educational modules. In the parent R01 project, the
necessary CDSS functionalities were planned to be developed and tested as internal codes without
documentation or user instructions, nor was the educational component planned.
Meanwhile, we continue to explore a more generic solution to the issues that can benefit clinicians and
patients by enhancing clinical care services. We anticipate that the newly added CDSS modules will facilitate
more consistent preventive services to the populations served by both systems. Due to our efforts, the
modules’ clinician users can provide services in a self-sustainable manner.
The two new modules can be used as CDSS teaching platforms to educate students and trainees about the
life cycle and technical mechanisms of CDSS regarding its operation, configuration, management,
maintenance, and monitoring. For medical and health students without access to operational electronic
medical records (EMR) systems or CDSS, students can obtain CDSS experience via hands-on sessions using
these modules. For computer science students, these modules can facilitate understanding of basic terms of
clinical care within EMR contexts. We anticipate that the educational modules will (1) prepare future CDSS
users and designers more comprehensively, (2) empower them to optimize the CDSS and maximize the full
potential of CDSS, and (3) better prepare the future workforce for healthcare IT. In practical terms, our newly
proposed project will benefit existing and future OpenMRS and OpenEMR users and their patients. This work
will help us achieve our goal for the parent R01 project. The experience obtained through the work of the
CDSS modules will help us understand the interoperability of CDSS rules conceptually, pinpoint the underlying
issues of interoperability, and shed light on future directions in tackling interoperability on a larger scale.

Public health relevance
This administrative supplement project will transform internal codes into a ready-to-distribute clinical decision support (CDS) module for OpenMRS [an open-source electronic medical record (EMR) system], an enhanced CDS module for OpenEMR (another open-source EMR system), and will generate educational modules on CDS and its work mechanisms. The CDS modules, which will include the Centers for Disease Control and Prevention (CDC)-recommended immunization schedules, can reach broader and existing user communities of OpenMRS and OpenEMR and potentially change clinical care delivered via these systems and enhance the health of patient populations served by these systems. The educational modules will help better train the future healthcare information technology workforce, especially on CDS.